Leadership and Administrative Core

ABSTRACT
The Resource Center for Alzheimer’s and Dementia Research in Asian and Pacific Americans (RCASIA)
has missions of 1) increasing scientists underrepresented in AD/ADRD-related Behavioral, Social, and
Economic Research biomedical research through innovative models of mentoring and community interaction;
2) advancing the rigor and impact of AD/ADRD pilot studies in older APAs through Common Data Elements
and data-sharing; 3) serving as a national resource for linguistically/culturally tested and validated tools to
assess cognition, function, and AD/ADRD care in APA populations. The Leadership and Administrative Core
(LAC) – led by former traditional RCMAR MPIs William Hu, MD, PhD (contact PI) and Bei Wu, PhD – will
oversee all administrative tasks including communication and coordination with NIA, RCMAR Coordinating
Centers, and affiliated institutions (including NIH-funded APA health-related centers and Alzheimer’s Disease
Research Centers). The LAC will provide timely set-up of subcontracts and payments associated with Scientist
pilot projects; ensure that each project adheres to the Behavioral, Social, and Economic domains and the
theme of People, Culture, Place, and Time; convene the Executive Committee and the External Advisory
Committee; review the implementation of Common Data Elements and data-sharing practices; recruit former
RCMAR/RCASIA Scientists as consultants in Pods; and evaluate – in collaboration with REC, Cores, and EAC
– the effectiveness of the novel Pod/Team mentoring model. The LAC will continue to build long-lasting
relationships with RCASIA parent/affiliated institutions, partner studies (New Jersey Population Cohort Study,
Rutgers-Stanford Chinese Older Adult Study, planned New Jersey cohort for Mediators of Atherosclerosis of
South Asians living in America), mentors, and EAC. Finally, the LAC will monitor faculty-staff, mentor-mentee,
and other working relationships to provide first level conflict resolution; bring to the attention of ExC and EAC
challenges related to Scientists or RCASIA programs; and revise Pod/Team and other programmatic designs
as needed in consultation with ExC, EAC, and NIA.